NINDS Research Education Programs for Residents and Fellows in Neurosurgery

PROJECT SUMMARY
The brain is the most frequent site of crippling and incurable human disease. Neurosurgeons are ideally
positioned to advance and translate neuroscience discoveries, but it is a stark minority that are able to build a
career as a physician-scientist successfully. Training programs, including our own, have been deficient in their
provision of three essential components to delivering neurosurgeon-scientists to the field: 1) Opportunity; 2)
Mentorship; 3) Continuity.
We have examined the difficult truth of poor productivity from our prior R25 awardees, dissected our
failures, and designed new and innovative programmatic approaches, specifically molded to 1) expand
opportunities; 2) re-address mentorship; and 3) redefine entirely the look of sustained departmental
commitment to developing and maintaining neurosurgeon-scientists. Herein, we offer a fresh enthusiasm,
focus, and approach for addressing the problem of how to deliver and sustain neurosurgical research
contributions.
The program proposed here provides a unique and organized approach to engage, support, and maintain
neurosurgery trainees in mentored research. Our hypothesis is that implementation of a formal physician-
scientist training track, coupled with a committee-based mentored research experience and an unprecedented
commitment to longitudinal support for trainees who secure funding will result in improved realization of
independently-funded academic careers for neurosurgeon-scientists. Toward that end, our Specific Aims are to
optimize/provide:
1. Opportunity. Our neurosurgery residency has been re-designed to include a Physician-Scientist Track
that proffers a weekly Academic Day during junior residency, a PhD-thesis style Research Mentorship
Committee, a core curriculum, a vetted and reviewed R25 application, mentored/supported research PGY
years 4-6, and a 7th “transition to practice” year that teaches trainees to divide time successfully between
clinical and research responsibilities.
2. Mentorship. Physician-Scientist Track residents will identify a primary research mentor from among 29
approved Duke faculty mentors grouped into 9 distinct Research Concentrations. A PhD-style Research
Mentorship Committee will be formed to mentor the resident throughout training.
3. Continuity. R25 recipients will receive matched funds from Neurosurgery to support their research
endeavors during the clinical years separating their R25 award in PGY4 from the PGY7 “transition to
practice” year.

Public health relevance
PROJECT NARRATIVE The current design of neurosurgical residencies and changes to training priorities have imposed troublesome restrictions on our ability to foster and retain neurosurgeon-scientists. This proposal describes an innovative program to cultivate and maintain the interest and capability of neurosurgeon-scientists by providing newly formatted opportunities, mentorship, and continuity. Our residency has been specifically redesigned to recruit, train, and propel neurosurgeon-scientists into an NIH-funded academic career.